Investigation of how sex steroids and nicotinic acetylcholine receptors promote cocaine self-administration

PROJECT SUMMARY/ABSTRACT
About 12 million individuals over the age of 12 have a substance use disorder (SUD). Cocaine is involved
in about 1 in 5 overdoses in the United States and is abused by both men and women. Women are more
vulnerable to the rewarding effects of cocaine and more rapidly progress from initial use to dependence than
men but the neurobiological mechanisms that contribute to these differences are yet to be determined. A
limitation of the current work investigating sex differences in preclinical research is that the research is primarily
focused on hormonal contributions that may be driving sex differences. There is little understanding of how sex
steroids and other neurobiological mechanisms contribute to cocaine dependence. The overall goal of this
project is to identify the effects of a history of cocaine self-administration on sex steroids and nicotinic
acetylcholine receptor (nAChRs) subunit expression and to test the hypothesis that decreased nAChRs
alpha 5 (ɑ5) in the dorsal hippocampus (dHIPP) produced by decreased progesterone levels promote
cocaine self-administration behavior. Aim 1 will use single-cell transcriptomics to identify sex differences in
the dysregulated transcriptional networks in rats with a history of compulsive-like cocaine self-administration
using brain (dHIPP), adrenal, pituitary, reproductive organ samples. Aim 2 will causally investigate the role of
the nAChR ɑ5 in the dHIPP and progesterone on cocaine self-administration behavior using an AAV-ShRNA to
knock down nAChRs ɑ5 in the dHIPP and pharmacology to block the progesterone receptor. These projects will
be the first to look at associations between sex steroids and nAChR ɑ5 in the dHIPP on cocaine selfadministration in both sexes. My Sponsor, Dr. Olivier George (UCSD) is an expert on the neurobiology of drugs
of abuse and addiction and is recognized as an innovative leader in the field of drug abuse and, therefore, the
perfect fit to mentor me for the proposed research. The proposed Research and Training Plans will deepen my
knowledge of transcriptomics, the cholinergic system, the hippocampus, and neuroendocrinology in addictionlike phenotypes and will expand my expertise in cocaine dependency. The training I will receive in single-cell
transcriptomics, ELISAs, bioinformatics, intrajugular catheter surgeries, and advanced operant paradigms will
give me the skills necessary to answer questions focused on cell-specific differences in males and females that
may be driving dysregulation of reward circuitry pre- and post-drug exposure. The training I have received in the
F99 phase and the training I will receive in the K00 phase will allow me to establish a lab where I can research
my long-term research goal of investigating the mechanisms underlying maladaptive addiction behaviors and
how these behaviors differentiate by sex.

Public health relevance
PROJECT NARRATIVE Women are more vulnerable to the rewarding effects of cocaine and more rapidly progress from initial use to dependence than men but the neurobiological mechanisms that contribute to these differences yet to be determined. This project will use a combination of single-cell transcriptomics, blood hormone level assays, pharmacology, and RNAscope to investigate how sex steroids and nicotinic acetylcholine receptors (nAChRs) alpha 5 (α5) contribute to sex differences in cocaine self-administration. The overall goal of this project is to identify the effects of a history of cocaine self-administration on sex steroids and nAChRs expression and to test the hypothesis that decreased nAChR α5 in the dHIPP produced by decreased progesterone levels promote cocaine self-administration.